Atlanta Network for Training In KUH Scientific Research (ATLANTIS)

TL1 ABSTRACT:
We propose an integrated, city-wide Network for KUH research training (TL1 Training Core) for pre- and postdoctoral trainees doing original KUH research under the mentorship of experienced, scientifically diverse
preceptors. We will create a vibrant, supportive and dynamic training environment to encourage trainees to
investigate key KUH related questions affecting human health and disease. This U2C-TL1 training mechanism
will connect the abundant and diverse clinical, translational, and basic science resources available in the Atlanta
scientific community, creating a cohesive program promoting collaborative, supportive, interdisciplinary
research. The “Atlanta Network Training In KUH Scientific Research (ATLANTIS Program)” will promote
kidney, urologic, and hematologic research training for pre- and postdoctoral trainees at Emory University,
Georgia Institute of Technology (GA Tech), and Morehouse School of Medicine. Each provides unique training
opportunities and complementary scientific strengths. We will recruit a talented pool of young scholars both
locally and nationwide, including women and members of underrepresented minorities. To recruit outstanding
trainees, the Network and TL1 Cores will work together to promote KUH research and ATLANTIS training among
undergraduates, particularly at HBCUs, graduate students and postdoc trainees. Through required and elective
coursework, ATLANTIS will provide predoctoral and postdoctoral scholars with the core competencies and skills
they need to achieve their specific goals and to succeed in a KUH research-intensive career. We will provide
mentored training in essential and innovative research techniques, data analysis, scientific writing, and oral
presentations. Trainees will meet with their mentor and Program Leadership at regular intervals to review their
accomplishments and goals, as well as to identify future opportunities. Mentors will discuss the scholar’s
challenges and guide them in finding solutions to these roadblocks. We will continually evaluate and improve the
program based on trainee and mentor feedback. The program’s success and areas for improvement will also be
identified based on an annual review of current and former trainee accomplishments, such as published
manuscripts, grants and patents, positions and promotions obtained, and honors received. Thus, the goals of
the ATLANTIS TL1 are to: 1) develop a network bringing together TL1 and other KUH trainees and mentors for
direct peer-to-peer communication, collaboration, and proactive engagement, 2) develop an integrated city-wide
institutional network for KUH research training and recruitment, 3) engage undergraduates, especially from
Atlanta HBCUs, and 4) develop an integrated professional development program that enhances trainee and
preceptor development. To achieve these goals, we will develop a broad mentor and leadership scientific training
base from KUH-related programs across Atlanta institutions.